Extracellular Vesicle Delivery System for Treatment of Abdominal Aortic Aneurysm

Project Summary/Abstract
Abdominal aortic aneurysm (AAA) is an enlargement of the aorta caused by loss of elastic fiber integrity in the
vascular wall. As the vessel grows, the risk of life-threatening rupture increases. Once the diameter reaches the
threshold of 5.5 cm, the risk of rupture is assumed to outweigh the risk of surgical intervention, the only current
method approved for treating AAAs. However, sub-threshold AAAs still rupture about 13% of the time,
demonstrating the need for a pre-threshold treatment to slow or halt aneurysm growth. Providing a regenerative
treatment that inhibits the degradation of elastic fibers and increases elastogenesis and collagen synthesis may
stabilize the vessel mechanically and slow aneurysm progression.
Local controlled delivery of a treatment to the aneurysm site would be ideal for avoiding systemic side effects. A
cell-based yet cell-free treatment would also provide similar regenerative effects to that of a cell-containing
treatment but would avoid the intense regulatory hurdles imposed on cell-containing therapies. In specific
reference to adipose stromal cells (ASCs), using their extracellular vesicles (EVs) can also avoid engraftment
and differentiation of the cells themselves while still exerting their regenerative effects. It is also important to
have sustained release of the treatment to exert its effects on the AAA for a longer period of time.
This proposal serves to develop a magnet-localizable controlled release system of EVs. This system will be
validated using vascular smooth muscle cells (VSMCs) seeded in 3D fibrin gel constructs, specifically looking at
how the delivered EVs modulate matrix-related gene expression and elastin and collagen deposition. To test
how these EVs could reach the medial VSMCs in an AAA through adventitial administration, EVs will be
evaluated for movement into aneurysmal-like porcine aortas. Based on these experimental results, a
computational transport model will be developed to predict movements of EVs into aneurysmal tissue. The
results of this project could serve as the foundation for a novel regenerative treatment of small AAAs and provide
a computational tool to model how external treatments can reach medial VSMCs. Through this project, the
applicant will learn research (both experimentally and computationally), communication, teaching skills as well
as scientific and clinical knowledge through her academic, research, and clinical mentors at the University of
Pittsburgh.

Public health relevance
Project Narrative Abdominal aortic aneurysm (AAA) is an expansion of the aorta caused by the breakdown of structural proteins within the vessel wall. There are only surgical options for treating large AAAs that are at the highest risk of rupture, and currently no treatments for small AAA, which will become a high risk if ignored. The proposed research will investigate how a localized delivery system of stem cell secretions can stimulate restoration of structural proteins to pave the way for a new, non-invasive treatment of small AAAs.